Community Data Hub for Integrative Visualization

Project Summary
The rich, diverse, and complementary multimodal datasets provided by the Common Fund Data Ecosystem's
(CFDE) Data Coordinating Centers (DCCs) provide exciting opportunities for integrative analysis and
exploration. Here, we propose a systematic data visualization-driven approach to investigate the model-based
predictions of the target genes of candidate cis regulatory elements (cCREs). Our project will leverage
biomolecular data from key repositories in the CFDE, including the Genotype-Tissue Expression (GTEx)
project, the Human BioMolecular Atlas Program (HuBMAP), the Cellular Senescence Network (SenNet), and
the 4D Nucleome (4DN) consortium, and will expand to include genomic data from external large projects
such as the Encyclopedia of DNA Elements (ENCODE) project. Our motivating use case is the integrative
exploration and validation of predictions for target genes of cCREs in the context of relevant linkage
disequilibrium (LD), molecular quantitative trait loci (QTLs), epigenomic, transcriptomic, (spatial and
non-spatial) single-cell, and Chromosome Conformation Capture (3C/Hi-C) data. Central to this objective are
(1) a ﬂexible data management system tailormade for visualization that addresses the challenges of organizing
private and federated public datasets, (2) tools for the creation of custom, interactive exploratory
visualizations, and (3) the ability to save and share visualizations in a FAIR manner. To achieve our goals, we
will develop the Common Fund Visualization Hub, a cloud-based platform enabling uniﬁed access to data
resources in the CFDE alongside user-contributed, private data in projects. It will provide a ﬂuid metadata
tagging system that supports structured and unstructured tags. It will support multiscale, genomic
visualization using HiGlass along with a user interface for on-the-ﬂy visualization construction based on the
Gosling visualization grammar. It will also support multimodal data visualization using Vitessce and enhance
reusability through sharing of visualizations and storytelling features to communicate discovery processes.
The Common Fund Visualization Hub will thus facilitate comprehensive data interpretation and
communication through integrative, interactive analysis of diverse genomic and bioimaging datasets. Using
this platform, we will evaluate and compare regulatory element-to-gene predictions from leading machine
learning models based on diﬀerent evidence-based methodologies. By streamlining integrative visualization of
existing CFDE data, our platform aims to help maximize the utility of CFDE investments to accelerate
biomedical discovery. Our platform will empower community members to independently browse, record, and
present their own data combined with data sourced from across the ecosystem, enhancing collaboration and
communication both within and across research groups, as well as with the broader community and the
general public.

Public health relevance
Narrative The Common Fund Visualization Hub project aims to develop a transformative cloud-based integrative visualization platform to enable interactive exploration of multimodal biomedical data, using large omics and imaging datasets sourced from CFDE DCCs and external consortia. The Hub's innovative architecture, focusing on user-driven visualization construction and storytelling, promises to accelerate discovery and improve the accuracy of predictive models in genomic research. The Hub will be used to evaluate models predicting the target genes of candidate cis regulatory elements, which is of great importance to dissecting the biological function of noncoding genetic variants in human traits and disease.